Hepatic Rap1a in cholesterol homeostasis

PROJECT SUMMARY
Title: Hepatic Rap1a in cholesterol homeostasis
Atherosclerotic cardiovascular disease is the leading cause of death worldwide and lowering of proatherogenic
low-density lipoprotein (LDL) cholesterol (LDL-C) levels is the primary target of therapy. Recent work has
identified proprotein convertase subtilisin/ kexin type 9 (PCSK9) as a promising therapeutic target that regulates
serum LDL-C. Despite its critical role as a regulator of the LDL receptor (LDLR) and attractiveness as a
pharmacological target, the mechanism(s) by which PCSK9 is regulated remain largely unknown. Interestingly,
the most widely prescribed drugs for lowering plasma cholesterol, statins, dose-dependently increase PCSK9
levels, which largely negate further statin-induced increases in hepatic LDLR and attenuate their efficacy.
However, our understanding of the underlying cellular and molecular mechanisms of this regulation remains
incomplete. This proposal is based on a new finding from our laboratory suggesting that activation of the small
G protein of the Ras superfamily, Rap1a, lowers PCSK9 and plasma LDL-C levels. Further, Rap1a
geranylgeranyl prenylation and activity is inhibited in statin-treated hepatocytes and human liver, and restoring
intracellular geranylgeranyl isoprenoid levels prevents statin-induced PCSK9 and further lowers LDL-C. We
propose that hepatic Rap1a is a novel regulator of PCSK9 protein, and its inhibition via lower intracellular
isoprenoid levels may provide an additional mechanism to explain how statins increase PCSK9. Based on these,
we will define the mechanisms by which Rap1a regulates PCSK9 and LDL-C metabolism (Aim 1), elucidate it’s
in role statin-mediated PCSK9 induction (Aim 2), and explore the effect of combined statin and Rap1a activation
in the prevention of atherosclerotic lesion development. (Aim 3). We will test these new ideas in vivo and ex vivo,
using a combination of mouse genetic, physiological, and biochemical approaches.

Public health relevance
PROJECT NARRATIVE Atherosclerotic cardiovascular disease (CVD) is reaching epidemic proportions throughout the world and is a major burden to healthcare systems and societies worldwide. The objective of this proposal is to explore the novel hypothesis that geranylgeranyl isoprenoids and hepatic Rap1a regulate plasma low-density lipoprotein levels and contributes to the CVD development. Successful completion of these studies will reveal a new mechanism involved in the regulation of cholesterol homeostasis and may offer new therapeutic targets for hyperlipidemia-driven CVD.